The International CD1-MR1 Workshop

Project Summary
The International CD1-MR1 Workshop is the premier international conference focusing on the latest science
regarding non-classical T cells, which are broadly defined by their lack of MHC restriction. This 4-day workshop
has been held since 2000, and brings together T cell experts from around the world. Beyond MR1-restricted
mucosa associated invariant T (MAIT) and CD1d-restricted NK T cells, this international forum describes new
CD1- and MR1-restricted T cell populations participating in human inflammatory, autoimmune and infectious
disease, as well as translational sessions describing new reagents to treat human T cell mediated diseases. The
upcoming 2025 CD1-MR1 workshop will be held from September 9-12, at Oregon Health Science University in
Portland, Oregon, and aims to further build the CD1-MR1 field by stimulating collaborations between early career
and senior scientists in a setting conducive for networking. We have designed programs supporting visibility for
trainees, as well as special lectureships for early and mid-career scientists. The recent establishment of an
international CD1-MR1 Society will increase participation, further aided through travel awards to support students
and postdoctoral fellows, social and scientific functions that are specifically designed to promote international
interactions. Requested funds will primarily be allocated towards merit-based travel awards as well as reduced
registration fees for early career investigators

Public health relevance
Project Narrative The International CD1-MR1 workshop brings together T cell immunologists from all continents and all career stages and provides opportunities to discuss new developments in the field of non-MHC restricted T cells, and initiate new collaborations and exchange of ideas and expertise. CD1- and MR1-restricted T cells cell populations are known to play a role in human inflammatory, autoimmune and infectious disease, as well as in malignancies, making this an active field of research translation with broad clinical relevance. The CD1-MR1 workshop stimulates collaborations between early career and senior scientists, provides programs to increase visibility for trainees, as well as special lectureships for early and mid-career scientists, and is overall designed to promote international networking.